Epigenetic control of developmental gene regulation

PROJECT SUMMARY
Although multiple epigenetic processes contribute to developmental gene regulation, the mechanisms by which
they rewire gene regulatory networks during lineage specification are often unclear. Defects in epigenetic gene
regulation contribute to developmental disorders and disease. Nuclear RNAs, including multiple classes of
non-coding RNAs and nascent transcripts of coding genes help regulate the epigenetic landscape and facilitate
developmental gene regulation. We have focused on the functions of R-loops—RNA/DNA hybrids that most
often arise when nascent transcripts hybridize to their DNA templates—in the control of epigenetic gene
regulation in mouse embryonic stem cells (mESCs). We previously discovered that R-loops modulate binding
of the Tip60-p400 chromatin remodeling complex and partial depletion of R-loops from mESCs impairs the
fidelity of differentiation. However, the precise roles of R-loops in differentiation are unclear. We have recently
taken systematic and unbiased approaches to identify how R-loops impact the epigenome of mESCs and
uncover how depletion of R-loops disrupts differentiation. In addition, we uncovered R-loop binding proteins
that likely mediate some of their regulatory functions. We further developed new, single-cell genomic tools
necessary to uncover how R-loops and other classes of nuclear RNAs meditate their effects in different
lineages. Here, we propose to characterize the effects of one novel R-loop binding protein that functions in
gene regulation and is essential for cell proliferation. In addition, we will examine the roles of R-loops in
transcription elongation, fidelity, and RNA processing. Finally, we will leverage novel tools we developed for
simultaneous profiling of epigenetic features to identify the locations of R-loops and epigenetic marks during
gastrulation, where the three primary germ layers are established from pluripotent progenitors. Drawing on this
in vivo atlas, we will use an inducible RNaseH1 mESC line to disrupt R-loops in an ESC differentiation model,
uncovering their cell type-specific targets and mechanisms by which they control developmental gene
expression. Together, these studies will uncover the functions of a key mediator of R-loop dependent gene
regulation, the mechanisms by which R-loops modulate epigenetic marks critical for transcriptional fidelity, and
the developmental targets of R-loops. These studies will significantly expand our understanding of RNA-
mediated gene regulation and its roles in establishment of the mammalian body plan.

Public health relevance
PROJECT NARRATIVE Chromatin-associated RNAs regulate gene expression and cell fate decisions during embryonic development. R-loops—nuclear structures that arise from hybridization of nascent RNA transcripts to their DNA templates— have important roles in regulation of chromatin structure, but also can contribute to genome instability. We will dissect the mechanisms by which R-loops carry out their regulatory functions and contribute to developmental cell fate.